Analysis of Nematode Sex Determination and Dosage Compensation

PROJECT SUMMARY
Studies are proposed to dissect one of the fundamental, binary development decisions that most
metazoans make: their sex. The nematode C. elegans determines sex with remarkable precision by tallying X-
chromosome number relative to the sets of autosomes (X:A signal): ratios of 1X:2A (0.5) and 2X:3A (0.67)
signal male fate, while ratios of 3X:4A (0.75) and 2X:2A (1.0) signal hermaphrodite fate. We have discovered
much about the nature and action of the X:A signal and its direct target, a master sex-determination-switch gene
that also controls X-chromosome dosage compensation. However, a fundamental question remains: how is the
signal interpreted reproducibly in an "all or none" manner to elicit fertile male or hermaphrodite development, never
intersexual development? We pioneer new methods using machine learning neural networks to address this
question with single-molecule and single-cell resolution. We also propose to dissect the functional interplay
between chromatin modification and chromosome structure in regulating gene expression over vast
chromosomal territories. X-chromosome dosage compensation in C. elegans is exemplary for this analysis: we
found recently that dosage-compensated X chromosomes have (i) elevated levels of modified histone
H4K20me1 compared to autosomes and (ii) a unique three-dimensional architecture. Both are imposed by the
dosage compensation complex (DCC). Loss of H4K20me1 disrupts 3D architecture and elevates X gene
expression. In the nematode DCC, one subunit is an H4K20me2 demethylase and five subunits are homologs
of condensin subunits, which compact and resolve mitotic and meiotic chromosomes. All DCC subunits are
recruited specifically to hermaphrodite X chromosomes by an XX-specific subunit that triggers binding to cis-
acting regulatory elements on X (rex) to reduce gene expression by half. The DCC remodels the structure of X
into topologically associating domains (TADs) using its highest affinity rex sites to establish domain boundaries.
Despite this knowledge, important questions underlying the mechanisms of dosage compensation remain.
What DCC subunits recognize the X-enriched motifs in rex sites to bind X directly? How does the DCC regulate
RNA polymerase II to repress gene expression? What mechanisms underlie H4K20me1's control of
chromosome structure, and how does DCC-mediated higher-order structure affect gene expression? Our
findings should have broad implications, because (i) condensin complexes control chromosome structure from
bacteria to man, (ii) H4K20me1 is enriched on the inactive X of female mammals, (iii) demethylases are linked to
tumor progression, and (iv) the H4K20me2 demethylase modulates nematode growth, metabolism, and entry into
the quiescent dauer state. Lastly, we will exploit our unexpected finding that rex sites have diverged across
Caenorhabditis species separated by 30 MYR, retaining no functional overlap despite strong conservation of the
core DCC machinery. This divergence provides an unusual opportunity to study the path for a concerted co-
evolutionary change in hundreds of target sites across X chromosomes and the protein complexes that bind them.

Public health relevance
PROJECT NARRATIVE Our work dissects one of the fundamental, binary developmental decisions that most metazoans make: their sex. While we have discovered detailed molecular mechanisms about the nature and action of the signal that determines sex in the nematode C. elegans and its direct target, a critical question remains that we address: how is the sex signal interpreted reproducibly in an "all or none" manner to elicit fertile male or hermaphrodite development, never intersexual development? Our work also explores the functional interplay between chromosome structure, chromatin modification, and long-distance regulation of gene expression by studying X- chromosome dosage compensation. The nematode dosage compensation complex, a condensin complex, equalizes X-chromosome gene expression between the sexes by imposing a unique three-dimensional architecture onto hermaphrodite X chromosomes and by catalyzing enrichment of the modified histone H4K20me1 through a subunit that is a H4K20me2 histone demethylase. Results from exploring the connection between higher-order chromosome structure and chromatin modification should have broad implications, because (i) condensin complexes control chromosome structure from bacteria to man, (ii) H4K20me1 is enriched on the inactive X of female mammals, (iii) demethylases are linked to tumor progression, and (iv) the H4K20me2 demethylase modulates nematode growth, metabolism, and entry into the quiescent dauer state.